eCD4-Mediated Control of SIV Infection in the Brain

PROJECT SUMMARY
Combined antiretroviral therapy (ART) has revolutionized the treatment of HIV but ART regimens are not
without drawbacks. Cost, the need for daily administration, side effects, and social stigma all contribute to
reduced patient compliance. Moreover, despite treatment, some 15-55% of people living with HIV will develop
some form of HIV-associated neurocognitive disorder (HAND).
Because of these problems with ART regimens, we and many other investigators have been studying the use
of recombinant adeno-associated virus (rAAV) gene therapy vectors to deliver antibodies and other HIV
therapeutics to people living with HIV. Because expression from these vectors is essentially permanent;
patients could be protected for life from HIV infections with only a single AAV treatment (i.e. a ‘functional’
cure). Although numerous nonhuman primate experiments and two human clinical trials have been conducted
to study the use of AAV for functional cure, however, we are unaware of any efforts to determine whether or
not rAAV-expressed biologics can prevent or treat HAND.
We have developed an anti-HIV biologic called eCD4, a fusion of CD4-Ig with a carboxy-terminal co-receptor
(CCR5/CXCR4) mimetic peptide. We hypothesize that eCD4 is uniquely suited to preventing replication of
the neurotropic strains of HIV that preferentially infect the brain (macrophage-tropic isolates) because these
viruses necessarily evolve high affinity for CD4 to compensate for the low abundance of CD4 on macrophages
and microglia.
The organizing hypothesis of this project, then, is to determine if rAAV-delivered eCD4, either expressed from
the periphery or within the central nervous system, can prevent or treat HAND. To test this hypothesis, we
will use a pigtail macaque model of SIV-induced central nervous system disease, developed in our
laboratories, in which co-infection with an immunosuppressive swarm (SIV/DeltaB670) and neurotropic clone
(SIV/17E-Fr) establishes a highly reproducible CNS infection. Animals will be treated with ART until aviremic
and rAAV will be used to deliver a pigtail macaque version of eCD4 to skeletal muscle and/or brain tissue.
ART will be withdrawn to determine whether or not rAAV/eCD4 can prevent the re-emergence of CNS viremia.
If successful, these studies may open new avenues to the functional cure of HIV and treatment of HAND.

Public health relevance
PROJECT NARRATIVE Although small-molecule antiretroviral therapy (ART) drugs effectively control an HIV infection, there are drawbacks to their use, including their inability to prevent HIV-associated neurological disease in many patients. We have previously shown that expression of the exceptionally broad and potent antibody-like inhibitor eCD4, expressed from a gene-therapy vector, can protect from challenge with and often control infection of HIV model viruses. Here, we will determine if we can apply this approach to effectively treat the neurological consequences of HIV infection.